Harnessing Innate Immunity to Control the Neuroinflammatory HIV Reservoir

HIV-1 infects CD4+ T-cells, macrophages (MΦ) and microglia (MG) and affects all organs that are infiltrated by
permissive cells establishing viral reservoirs, including the brain. Even if treated with combined anti-retroviral
therapy (cART) neurocognitive impairment (NCI) develops in about 50% of people with HIV (PWH). HIV-1
triggers an interferon (IFN) response and type I IFNs (IFNα/β) can in principle control HIV-infection of CD4+ T-
cells and MΦ by interfering with several stages of the viral lifecycle. IFNβ exerts anti-viral and anti-inflammatory
effects and appears to at least transiently control HIV infection in the brain and periphery. We and others
observed that the endogenous, protective HIV/SIV-induced IFNβ response in the brain is transient but it is
unclear why and how HIV overcomes the IFN response. However, we also found: 1) Treatment of infected MΦs
with IFNβ diminished HIV-1 production; 2) The ISG IRF7 exerts negative feedback on IFNβ expression;, 3) IFNβ
protected neurons from toxins of HIV-stimulated MΦ; 4) An intranasal IFNβ treatment prevented neuronal
damage in a transgenic mouse model of NeuroHIV; 5) We identified the interferon-stimulated gene (ISG) CCL4
as a critical mediator of neuroprotection by IFNβ and found that astrocytes are the major source. Based on this
data, we hypothesize that IFNβ treatment in conjunction with cART can be utilized to restrict HIV-
infection or resurgence, formation of reservoirs and persistence in the brain as well as neuronal injury.
To test our hypothesis, we will employ primary human peripheral blood cells (PBMC), iPSC-derived MG,
astrocytes, 2D CNS and a novel microfluidic 3D CNS-on-a-chip tissue culture model, the latter including neurons,
astrocytes, microglia, pericytes, brain endothelial and immune cells spatially organized in a Mimetas device
(Mimetas Co, Gaithersburg, MD). We will use novel dynamic single cell imaging, transcriptomic and functional
approaches, to examine cell type specific effects of IFNβ relevant to viral infection and restriction,
neuroinflammation and neuronal toxicity and protection in the presence and absence of cART. Three Specific
Aims (SA) are proposed: 1. Dissect the impact of IFNβ on HIV-infected microglia and PBMC with and without
cART; 2. Define the role of astrocytes in the neuroprotective IFNβ response to HIV with and without cART, and
3. Assess in a novel 3D Blood/BBB/CNS-on-a-chip model, if IFNβ treatment can restrict HIV-1 infection, reservoir
formation and neurotoxicity in the presence and absence of cART. The Specific Aims will test the hypothesis that
IFNβ can restrict HIV-1 infection and reservoir formation in CD4+ T-cells, MΦ and MG, prevent HIV- and cART
induced injury to neurons and the blood-brain-barrier, and suppress resurgence of an established HIV infection
when cART is interrupted. The Specific Aims will test the mechanisms of IFNβ action with and without cART in a
cell type-specific approach, including induction of anti-viral and anti-inflammatory ISGs and neurotrophic factors,
activation of the pro-survival kinases Akt and ERK1/2, and suppression or reduced activity of infection-,
inflammation- and neurotoxicity-promoting factors, such as p38 MAPK and NFkB.

Public health relevance
HIV infection, AIDS and HIV-associated neurocognitive impairment remain a substantial public health concern despite combination anti-retroviral therapy. Therefore, the proposed research aims at harnessing the protective potential of anti-viral cytokines, such as interferon-β, against the formation of viral reservoirs and viral rebound and the associated neurotoxicity using human 2D and a novel 3D tissue culture model recapitulating on a chip the brain and its blood-brain barrier. The studies intend to find future therapeutic targets and thus new potential treatments for HIV-infection and persistence, and associated neurocognitive disorders via the analysis of intercellular and intracellular signaling mechanisms affected by HIV-1 and cytokines.